Longitudinal analysis of HIV reservoir and type I/III interferon system in people with HIV who initiated ART during primary infection

Abstract
Early initiation of antiretroviral therapy (ART) during primary HIV infection leads to clear public health benefits by
preventing onward HIV transmissions. However, it is not clear how the timing of early ART initiation affects
longer-term individual outcomes, such as chronic immune activation. Chronic immune activation during HIV
infection leads to immune dysregulation and exhaustion that contributes to disease progression and other clinical
problems. Heightened immune activation continues even after ART suppresses viral loads below the limit of
detection. Our group previously demonstrated that one pathway involved in immune activation, expression of
interferon stimulated genes (ISGs), is persistently upregulated during untreated and treated HIV infection.
Building on those results, we hypothesize that (1) effective antiretroviral treatment does not completely reverse
chronic ISG activation in people living with HIV, (2) chronic activation of the IFN system will be lower in people
with HIV (PWH) who started ART early, and (3) higher IFN system activation correlates with a larger proviral
reservoir. Identifying ISG pathways that remain elevated following several years of ART could identify targets for
preventing or treating co-occurring inflammatory and degenerative diseases, which are increasing in prevalence
as more and more PWH have remained on ART for decades.
To evaluate these hypotheses, we will use a highly unique set of archived samples, with longitudinal
samples from individuals prior to HIV infection, during primary infection, and after treatment initiation. These
samples come from a study of early ART initiation in which 1) individuals without HIV were followed monthly with
serology and RNA testing to detect HIV infections shortly after acquisition, and 2) participants diagnosed with HIV
were randomized to begin ART immediately or to defer ART for 24 weeks. They were followed with frequent visits
and sample collections for up to 4 years. In the proposed study, we will measure expression of ISGs in 40
participants (20 from each ART arm) before HIV infection, after HIV diagnosis but before ART and at 6, 30 and 48
months after ART is started. Using these data, we will determine whether ISG expression remains elevated after
48 months of ART relative to pre-infection samples from the same participant. Second, we will evaluate if
reduction of ISG expression following ART is different among those in the immediate vs. the deferred ART
initiation arms. Lastly, we will assess whether ISG activation correlates with the size of the latent HIV reservoir, as
has been suggested by animal models but remains unknown in humans.

Public health relevance
Narrative Medications to treat HIV, called antiretroviral therapy or ART, benefit individuals and society, but do not resolve all immune system problems in people with HIV infection (PWH). In this project, we will study whether one part of the immune system - the interferon-stimulated gene, or ISG, system - remains abnormal in PWH even when they are taking ART. This could help identify ways to target new treatments to reduce immune system problems that remain in PWH despite antiretroviral treatment.